Identifying Opportunities for Prevention of Adverse Outcomes Following Female Genital Fistula Repair

ABSTRACT
Female genital fistula is a debilitating injury that affects 2 to 3 million women, mostly in sub-Saharan Africa.
Women with fistula have uncontrollable leakage of urine and/or feces (among other physical symptoms), are
heavily stigmatized, and experience high psychiatric morbidity. Preliminary evidence has identified risk of
fistula recurrence, incontinence, and pregnancy complications following fistula repair. However, the evidence
base regarding the factors contributing to these adverse outcomes is severely underdeveloped, limiting the
development of clinical interventions to reduce these adverse risks to women, preventing them from re-
experiencing the consequences of fistula, and to improve pregnancy outcomes and quality of life.
In an effort to improve the physical and psychosocial quality of life for women affected by fistula, we propose to
address the critical gaps in knowledge on risk of adverse outcomes following fistula repair by conducting a
longitudinal cohort study of 800 women repaired for fistula in fistula repair facilities located in Uganda and
Kenya. We seek to identify predictors of post-repair fistula breakdown and recurrence (Aim 1), to identify
predictors and characteristics of post-repair incontinence (Aim 2), and to engage key stakeholders in a theory-
guided iterative process to develop a roadmap of intervention strategies likely to be feasible and acceptable
within this setting (Aim 3).
Our approach overcomes limitations to prior research through employing a longitudinal design; focusing on a
broad range of patient, fistula, and behavioral characteristics; and enrolling the largest number of women (800)
with the longest follow-up (3 years) to date for robust estimation. Data will be collected at time of surgery and
at 2 weeks, 6 weeks, 3 months, and quarterly thereafter for 3 years through a combination of interview-
administered patient questionnaire and structured medical record abstraction, with clinical exams conducted
per standard of care and as necessary based on symptom experiences. In-depth interviews with key
stakeholders (n~80, including longitudinal participants and a range of other important roles) guided by
prevalent behavior and implementation change theories will help us to understand facilitators and barriers of
behavior and implementation targets to inform potential intervention strategies at multiple levels.
Our sample size will allow us to detect a minimum difference in effect of 20% for all outcomes. Analyses will
describe estimate the individual and joint-effects of patient, fistula, fistula repair, and post-repair characteristics
on incidence of post-repair fistula breakdown and recurrence and incontinence using proportional hazards
frailty survival models. Our findings will inform counseling and clinical care models for optimizing post-repair
outcomes for women following fistula repair.

Public health relevance
PROJECT NARRATIVE Women affected by genital fistula experience significant physical and psychosocial morbidity associated with the condition, and nascent evidence suggests subsequent adverse outcomes occur after surgical repair (i.e., fistula repair breakdown or recurrence and incontinence). To identify salient targets for clinical and counselling interventions to improve women’s health and quality of life following fistula repair, we seek to understand the contribution of individual, fistula-related, and post-repair behaviors and exposures to these adverse outcomes. Subsequent and iterative work with key stakeholders will help us develop a road map of intervention strategies likely to be feasible and acceptable within the study population and setting.